AZT IN NEWBORN INFANTS EXPOSED TO PERINATAL HIV INFECTION

This is an ACTG sponsored four center safety, pharmacokinetic, and dose finding trial of AZT for infants one day to 3 months of age who are born to women with HIV infection. Dosing and intravenous and oral AZT pharmacokinetic studies are done on three occasions during the 6 week protocol. Participants are monitored closely for evidence of AZT toxicity and for development and progression of virologic and clinical evidence of HIV infection.